Strategic Scientific Pilot Support

The goal of the Strategic Pilots Incubator (SPI) is to coordinate CSSI-related FNLCR resources and projects to facilitate advancement of CSSI and trans-NCI initiatives. The SPI team will research, evaluate, recommend, develop, implement and assist with pilot projects, information systems, and services in support of CSSI and trans-NCI research initiatives, projects, and programs.